The Meharry Cancer Summer Research Program (SuRP)

PROJECT SUMMARY/ABSTRACT
Meharry Medical College seeks funding to support the continuation and expansion of the Meharry Cancer
Summer Research Program (SuRP), a research experiences program that has trained several students from
racial and ethnic groups that are traditionally underrepresented in health related sciences. This program will
address the issue of cancer health disparities by increasing student awareness of this issue and implementing
strategies designed to increase the diversity of the oncology and cancer research workforce. Meharry Medical
College is one of the largest historically black academic health science centers in the United States. It has a
proven commitment to training minority
physicians, dentists and scientists, and is a leading producer of African
Americans with PhDs in biomedical sciences.
The proposed summer program will provide an intensive, hands-on cancer focused research experience for
undergraduate and medical students through the lens of cancer health disparities. A diverse faculty of
experienced cancer investigators from Meharry Medical College and Vanderbilt Ingram Cancer Center will serve
as research mentors for the program. A nationwide search will be conducted to identify and select 10
undergraduate students and 5 rising second year medical students per year who are interested in careers in
medicine and biomedical science. Students will complete short-term 9-week (medical) or 10-week
(undergraduate) research projects that focus on cancers which disproportionately affect racial and ethnic
minorities. Projects will include multiple types of cancer research, such as basic science research, translational
research, bioinformatics, epidemiological and community based studies. Additional program enrichment
activities will include a cancer biology mini-course to teach participants fundamental concepts common to all
cancers. Students will gain exposure to clinical cancer research via molecular tumor boards and simulation-
based education. A weekly cancer health disparities research seminar will allow students to interact with
oncologists and cancer researchers from groups traditionally underrepresented in biomedical science and learn
about career opportunities within the areas of cancer research, oncology and cancer health disparities. Sessions
on the responsible conduct of research will be held on a weekly basis. Students will also participate in career
and professional development workshops that will 1) allow undergraduate students to explore career options
and obtain information needed to apply and successfully gain entrance into M.D. and Ph.D. training programs
and 2) allow medical students to successfully complete medical training and apply for residency programs.
At the end of the summer, participants will share their research findings through oral and poster presentations.
Program directors and staff will track participants through the remainder of their undergraduate/medical training
and post graduate experiences to evaluate whether program goals were met, and identify areas for improvement.
Data from participant and research mentors will also be used to evaluate and enhance the program.

Public health relevance
PROJECT NARRATIVE Both increased awareness of cancer health disparities and increased diversity within the cancer research/oncology workforce are required to fully address the problem of cancer health disparities. The proposed Meharry Cancer Summer Research Program (SuRP) will provide undergraduate and medical students an opportunity to complete short-term, cancer focused research experiences that will enhance their understanding of cancer and cancer health disparities. It will also inspire participants to pursue careers in cancer research.